Molecular Diagnosis, Prognosis, and Therapeutic Targets in Mantle Cell Lymphoma

Mantle cell lymphoma (MCL) is an aggressive lymphoid neoplasm considered incurable with current therapies.
However, recent studies have recognized a subtype of leukemic non-nodal MCL (nnMCL) with indolent course
that may be amendable to conservative management for long periods. The mechanisms leading to this
disparate behavior are not well known. Furthermore, biological criteria to justify conservative management or
determine the most appropriate treatment are not well defined. Previous studies have shown the relevance of
CCND1 and SOX11 oncogenic events in MCL deregulating cell cycle, B-cell differentiation program and
tumor/microenvironment interactions combined with alterations in the DNA damage response (DDR) and
survival pathways. However, these events do not capture the full clinical heterogeneity. We hypothesize that
this diversity may stem from the different cell-of-origin of the tumors combined with genomic instability that
seems to run in parallel with increasing changes in their epigenetic profile. The long term goal of our project is
to understand the genomic, epigenomic and molecular mechanisms driving the biological and clinical diversity
of MCL, to define targets that may open new therapeutic strategies and to identify biomarkers that can provide
strong biological support for management decisions. Our specific aims are: 1) To investigate the role of
CCND1 in the generation of MCL diversity, beyond its cell cycle regulation, promoting chromosomal
instability or dysregulating other cellular processes and possible interactions with SOX11. We will use different
cell models overexpressing and silencing CCND1 in different cell contexts of SOX11 expression in order to
study DNA replication stress, interactions of CCND1 with the replication and transcription machineries,
activation of DDR, and strategies to interfere with these mechanisms; 2) To identify secondary genomic and
epigenetic alterations that may drive the different clinical and biological behavior of conventional and
non-nodal MCL. We will exploit the recent whole genome/epigenomic data generated by our group and will
complete the landscape of alterations in metachronic paired samples at diagnosis and progression or relapse.
We will also characterize the progressive epigenomic changes in relationship to the genomic complexity of
MCL and define their role in the clinical evolution of the patients; and 3) To identify novel biomarkers for
therapeutic intervention and risk stratification of the patients beyond the proliferation activity and validate their
clinical impact in large cohorts of patients with both MCL subtypes. This integrated genomic/epigenomic
perspective of MCL together with a better understanding of the mechanisms leading to its genomic instability
should provide solid biological bases for new management strategies and targets for therapeutic intervention.

Public health relevance
Narrative: According to the NCI goals, Project 2 will provide information about the biology of mantle cell lymphoma, including comprehensive genome characterization that will contribute to understanding how therapies may work in these tumors. The information generated will provide biological guidelines to predict the best management strategies for the patients. We also will develop and validate biomarkers to predict response to standard treatments through retrospective analysis of patient specimens.